Core A: Administrative Core

ADMINISTRATIVE CORE (Core A): PROJECT SUMMARY/ABSTRACT The Administrative Core is responsible for the strategic planning, overall management, and coordination of the Program Project (P01) “Molecular Mechanisms of the Dysregulated Immune Response to Ebola Virus”. It provides governance, financial oversight, and operational management functions to facilitate the execution of the overall research plan, thereby enabling the Program to fulfill its mission to characterize the transcriptional, posttranscriptional, and posttranslational mechanisms following Ebola virus infection that lead to the dysregulated immune response. The Administrative Core will provide an organizational and programmatic structure to promote research productivity and synergy through scientific interactions. The Core will provide oversight in setting priorities, including decision-making processes involving the continual evaluation of research by the PIs and an advisory board. Core personnel will ensure that the Program includes biostatistical rigor and is compliant with issues involving the use of vertebrate animals, select agents, and BSL-4 facilities, and will ensure that regulatory expertise is available for future product development activities. Management activities are carried out with the advice of the External Advisory Committee in close collaboration with Core leadership. Emails, teleconferencing, and videoconferencing are maximally utilized to facilitate communication between the University of Texas Medical Branch, the lead institution for the P01, and participating institutions.